Regulatory Elements in Dilated Cardiomyopathy

DESCRIPTION (provided by applicant): This proposal entails a five-year training program focused on preparing the applicant for an independent career in academic cardiovascular medicine. This project aims to impart the skills and knowledge required for the applicant to achieve his long-term goal of bringing genomic insights into cardiovascular disease. The immediate training objectives of the applicant are to learn more sequencing techniques, to analyze datasets with more sophisticated network models, and to acquire further bench experience to validate in silico findings. Other objectives include developing administrative skill required to function autonomously and composing a body of work that will enable funding as an independent investigator. Under the guidance of his long-term mentor Michael Snyder and his carefully selected advisory committee of senior investigators, the applicant will have the resources and support to achieve these goals and transition to independence. Project Description Heart failure affects nearly six million Americans. Dilated cardiomyopathy (DCM) represents the largest class among those with systolic heart failure. Genetics is thought to play a role in only a minority of cases; yet, whatever the cause, including genetic, the enlarged left ventricles and thin, poorly contracting myocardial walls characteristic of the hearts of all these patients represent the outcome of a final common pathway. This structural remodeling is reflected on the molecular level by changes in the transcription of genes. Already, previous work in a murine system has shown the involvement of molecules affecting chromatin accessibility leading to the ectopic expression of fetal genes in dilated cardiomyopathy tissue. However, a global, systematic study of multiple layers of the epigenome and transcription factors has yet to be performed on human DCM tissues. Even before that, though, the rules regarding the governance of transcription by regulatory elements is only beginning to be understood. This proposal seeks to model elements of the regulome in model cell lines and normal tissues before trying to understand their alterations in diseased states. The ultimate goal is to apply integrativ analysis involving global, regulatory element data to gain new insights in the disease process of DCM and thereby uncover potential new avenues for therapeutics.

Public health relevance
PROJECT NARRATIVE Heart failure is a debilitating and costly disease affecting nearly six million Americans. Dilated cardiomyopathy represents the most common form of heart failure. Even though dilated cardiomyopathy can be caused by many different reasons, in the end, the diseased hearts of these patients have similarities in size and shape. These changes are sure to be reflected on the molecular level by changes in how genes are read. This project seeks to find out the dysregulation occurring in how genes are read in dilated cardiomyopathy as potential new avenues for therapy. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Elucidating the role of regulatory elements, e.g. the epigenome, transcription factors, etc., constitutes a next chapter in understanding how the human genome determines bodily processes. Harnessing next generation sequencing technologies, individual investigators as well as multi-center consortia have flooded the scientific community with many individual layers of the regulome. To integrate these data, analyses of ever increasing sophistication are required. At the same time, the field is beginning to examine how regulatory elements are involved in the pathogenesis of disease. One critical component still necessary to accelerate efforts is reference data on normal adult human tissues; so far, the majority of the data from consortia have been produced using cell lines, many representing immortalized or cancerous states. Obviously, how regulatory elements are altered in diseased tissues requires normal controls. If issues regarding data interpretation and normal tissue references of regulatory elements can be resolved, research into many human disorders stands to benefit. One disease of high priority is heart failure, which affects nearly six million Americans1. Dilated cardiomyopathy (DCM) represents the largest class among those with systolic heart failure. Genetics is thought to play a role in only 10-20% of cases2, but whatever the cause (of which there are more than seventy), all sufferers harbor enlarged left ventricles and thin, poorly contracting myocardial walls3. Even among the ~20% of those with familial forms for which the disease variant is identified2, how the mutation leads to downstream events culminating in the final common phenotype is poorly understood. In understanding the regulatory alterations underlying DCM, new avenues for potential, general therapies can be pursued in subsequent studies. This proposal seeks to address the various issues raised regarding the study of regulatory elements en route to examining their perturbation in DCM (Figure 1). Specific Aim 1: To fit a probabilistic graphical model to regulatory elements of cell lines H1 and IMR90. A great deal data on H1 and IMR90 are publically available. Yet, the regulatory rules of the epigenome and transcription factors (TFs) are incompletely understood. We hypothesize that a graphical probabilistic description of the rules governing regulatory elements is not only qualitatively the same across tissues but also quantitatively so. Thus, we will create a model predicting transcription using regulatory elements as features which will be applicable across these two cell lines. Specific Aim 2: To determine the common and distinguishing regulatory patterns for more than ten normal adult tissues, including heart. In the past, regression trees were fit using mainly transcriptome data to infer functional modules. We hypothesize that an integrative model including regulatory elements will lead to the inference of more accurate functional modules. Validity will be adjudged by how genes of known function from databases or the literature are accurately categorized. Specific Aim 3: To elucidate the regulatory alterations involved in the pathogenesis of DCM. With the regulatory features of normal tissues, specifically normal heart, characterized, we will proceed to uncover the transcriptional misregulation occurring in DCM. We hypothesize that specific modules affecting contractility and arrhythmic stability will be implicated by such an analysis. Specifically we seek to identify transcription factors which are responsible for large portions of the alterations. Figure 1. Schematic of the proposed research components of this proposal